The Molecular Basis for Integrin-Mediated Bidirectional Signaling

Leukocytes are essential immune components protecting the body against foreign invaders.
Adhesion, migration, extravasation, and cell-cell communication are mediated though the
bidirectional signaling of β2 integrins, which are integral membrane proteins found on the
leukocyte surface. Due to their complex and multifunctional roles, dysregulation of β2 integrins
is linked to autoimmune, cardiac and pulmonary pathologies as well as infectious diseases and
several cancers. Although integrins are prime therapeutic targets, drug development has been
hindered due to unanticipated side effects that arise from large gaps in our understanding of the
mechanisms that drive specificity and integrin activation. I will decipher the molecular basis for
β2 integrin activation, ligand recognition, and bidirectional signaling using an integrative
approach. I'll build on my expertise in cryoEM method development to capture high- resolution
conformational snapshots of isolated β2 integrin and ligand-bound complexes to reveal the
dynamic structural rearrangements associated with signal transduction and identify key residues
mediating ligand specificity. Using cell-surface expressed integrins, I'll assess the functional
consequences of mutating these residues on binding of ligands and conformation- specific
antibodies and on adhesion, phagocytosis, and cell motility. To gain broad insight into integrin
allostery in a near-native context, I'll develop a membrane mimetic system using next-
generation styrene maleic acid copolymers. Membrane lipids influence integrin activation and
ligand binding and are key to forming stable complexes. These polymers will afford a stream-
lined method to extract and purify nanodiscs embedded with pre- formed integrin-ligand
complexes in their native environment. I will use this system to study integrin in complex with
talin, the central integrin- activator protein that binds a conserved motif on the cytoplasmic
region on integrin. This will reveal in molecular detail how integrins are activated to relay signals
allosterically across the plasma membrane and define a molecular basis for bidirectional
signaling as well as provide a framework for designing biochemical, biophysical, and mechano-
sensitive experiments to study larger complexes and gain comprehensive insight into integrin
function. Ultimately, this work will provide a structural blueprint for the rational design of
therapeutics for autoimmune diseases, which is a long-term goal of the lab.

Public health relevance
Although 24 million Americans suffer from one of the 80 different types of autoimmune disease, the underlying causes are not well understood, and accurate diagnosis can be difficult. Leukocytes are essential immune components that should protect the body against foreign invaders, however dysregulation can instead lead to autoimmune diseases. We aim to uncover the regulation mechanisms and characterize the functions of transmembrane receptors that are highly expressed on the leukocyte surface to provide a blueprint for the rational design of highly-specific therapeutics for autoimmune diseases.